Training in Cardiovascular Research at the University of Hawaii

Abstract
This application for renewal of the Cardiovascular T32 training program at the University of Hawaii draws on
the strengths of our Center for Cardiovascular Research (CCR) and our established graduate program in Cell
and Molecular Biology. We also have maintained and enhanced an alliance with the Cardiovascular Division at
Stanford University Medical School to enrich the local academic environment and increase the number of
seasoned senior investigators available as mentors for our trainees. In recent years our medical school has
embarked on a new direction, emphasizing basic investigation that has instilled new energy into our graduate
programs. We have moved into a modern campus on the shore of Honolulu and attracted nationally
competitive investigators. Our Cardiovascular Center has recruited or developed 5 independent investigators
who have a principal focus on cardiovascular investigation. In addition we have a group of UH faculty with
established research programs pertinent to cardiovascular science. We now have the critical mass of
investigators needed for a successful T32 program. During our first cycle as the only T32 program at the
University of Hawaii we have had success in training under-represented minority scientists and in helping our
trainees to obtain independent grant funding. We still have our roots in our minority-serving, clinically-focused
school, but are adding an important level of scientific sophistication to serve our special location and
multiethnic population. During the second cycle of funding, described in this application, we will continue to
place our best graduate students and postdoctoral fellows in laboratories devoted to cardiovascular projects,
and provide mentoring that will help them succeed. They will benefit from an established curriculum, CCR core
resources, and will also be able to draw upon the Stanford Cardiovascular Division for world-class expertise
and research resources. We request support for three graduate students and three postdoctoral fellows per
year. We expect, on average, that the graduate students will be supported for no more than three years and
the postdocs for no more than two years before they either finish or obtain independent funding. Thus we
anticipate supporting approximately 7 individual postdoctoral fellows and 5 graduate students during the 5
years of this program. Our goal is to train our next generation of cardiovascular investigators, with special
attention to the priorities of our local population.

Public health relevance
T32 Narrative This application is for renewal of a training program that will provide support for predoctoral and postdoctoral trainees performing cardiovascular research at the John A. Burns School of Medicine at the University of Hawaii. !